CNS-Met Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
Research in CNS metabolism has garnered interest from many fields, including Alzheimer’s Disease, brain
injury (including traumatic injury, stroke, etc), epilepsy, and Parkinson’s Disease, and likely involves all areas of
CNS-related research. The University of Kentucky College of Medicine has made significant investments over
the last few years in both metabolomics instrumentation and investigators with metabolomics expertise that
enhanced existing UK strengths in neuroscience, cancer, cardiovascular, and diabetes & obesity research. The
objective of this application is to create an NIH Center of Biomedical Research Excellence (COBRE) in CNS
Metabolism (CNS-Met). This proposal builds on existing strengths at UK as well as strengths of both the senior
and junior investigators in brain physiology, neuropathology, and CNS metabolism. The CNS-Met
Administrative Core (Admin Core) will coordinate communication and access among the CNS-Met groups, the
above-mentioned metabolism-centric research programs, and other existing UK strengths as well as core
facilities established by other UK COBREs to support a multidisciplinary, team-based program that trains the
next generation of faculty focused on brain metabolism. The CNS-Met Administrative Core is directed by Dr.
Matthew Gentry and co-directed by Dr. Patrick Sullivan, senior scientists with complementary expertise in CNS
metabolism and demonstrated leadership skills. The Core will ensure and provide effective coordination and
oversight of research projects, research cores usage and service, general infrastructure, administrative, and
fiscal matters. It will provide robust and timely financial management and will facilitate internal communication
between CNS-Met constituents. It will be responsible for coordinating the recruitment of future research project
leaders and mentors and for managing and implementing pilot program funding. The Admin Core will do all of
these activities while ensuring that CNS-Met activities are in compliance with federal regulations. The
overarching goal of the CNS-Met Administrative Core is to deliver administrative, fiscal, and scientific
leadership and center-wide coordination to COBRE Research Project Leaders, their mentors, research
core, and other COBRE-supported investigators. To achieve these goals, the core will: 1) Coordinate
operational and fiscal management, infrastructure and program planning, and communication processes
across all COBRE components.; and 2) Facilitate and coordinate research training, mentoring, and career
development activities for early-stage investigators in brain metabolism research; 3) Implement a pilot studies
program to seed new research across neuroscience research thrusts; and 4) Provide effective formative and
summative assessment of COBRE projects and activities of the CNS-Met group.